Encapsulated Cell Based Oncolytic Virus Therapy for Brain Tumors

ABSTRACT
Glioblastoma (GBM) is the most lethal primary brain tumor with standard-of-care therapies providing only partial
palliation. One of the cornerstones of clinical care for GBM patients is surgical tumor debulking and subsequent
chemo- and radiotherapeutic treatment. Oncolytic herpes simplex virus (oHSV) that selectively replicate in tumor
cells and illicit antitumor effect via oncolysis and production of neoantigens are among the recently approved
promising therapies for cancer patients. Although phase I and Ib oHSV clinical trials in GBM patients have shown
signs of anti-tumor activity, clinical response rates have been sub-optimal primarily due incomplete understanding of
the immune evasion and oHSV delivery issues in the tumor resection cavity post-surgery. Considering the critical
and very limited timeline from diagnosis to primary surgical intervention in GBM patients, allogeneic “off-the-shelf”
engineered stem cells offer a promising therapeutic strategy to target residual GBM cells post-surgery. We have
previously demonstrated that MSC armed with different oHSV variants (MSC-oHSV) home to tumors and synthetic
extracellular matrix (sECM) encapsulated MSC-oHSV have a significantly better therapeutic efficacy than the
purified oHSV in GBM. These results although promising, have raised fundamental questions on how to develop
MSC based therapeutic approaches that specifically kill tumor cells and simultaneously activate immune effector
functions against GBMs. To enhance the therapeutic efficacy of MSC-oHSV, we have created oHSV resistant
CRISPR/Cas9 nectin-1 (utilized by oHSV as a mode of entry into the cell) knockout MSC (MSC-N1KO) thus allowing
us to co-deliver immunomodulators in combination with MSC-oHSV. Utilizing MSC-N1KO engineered
immunomodulator screening, we have identified interleukin (IL)-12, which is known to activate both innate and
adaptive immunity, to enhance the therapeutic efficacy of MSC-oHSV. Based on these findings, MSC-N1KO will be
engineered to express regulatable IL-12 and the therapeutic efficacy of co-delivered MSC-oHSV and MSC-N1KO-
IL12 will be tested in immune-phenotyped nodular and semi-invasive syngeneic GBM models of resection that we
have recently developed and characterized. Given that oHSV/IL12 mediated therapies upregulate programmed
death ligand (PD-L)1, MSC-N1KO-IL12 will be further engineered to express next generation of anti-PD-1 antibodies
(nanobodies; Nb) and the therapeutic efficacy and fate of encapsulated MSC-oHSV and MSC-N1KO-IL12/Nb-PD1
will be assessed in syngeneic GBM models of resection. We hypothesize that surgical resection-elicited recruitment
of immune effector cells at the residual tumor site will synergize with MSC-delivered oHSV, IL-12 and Nb-PD-1,
resulting in increased therapeutic benefit. To ease clinical translation, engineered human MSC will be developed
and tested in invasive and nodular patient derived GBM resection models in humanized mice. The integration of the
kill switch in MSC will ensure safety in our approach and the incorporation of imaging markers into both MSC and
GBMs will allow us to follow fate and efficacy in vivo and thus to fine tune the proposed approaches. We anticipate
that our findings will have a major contribution towards developing novel MSC based therapies for GBM and are
likely to define a new treatment paradigm for patients with other cancers.

Public health relevance
NARRATIVE: In this proposal, we will assess the fate and therapeutic efficacy mesenchymal stem cell (MSC) loaded oncolytic viruses (oHSV) combined with MSC expressing regulatable interleukin (IL)-12 and Nb-PD-1 in GBM models in vivo. The developed agents and strategies will be designed to be clinically translatable and should have a major impact in translating cell based therapies for a broad spectrum of metastatic tumors.